Core 08: Cyberinfrastructure Enhancement Core

Project Summary: Cyberinfrastructure Enhancement Core
The vision for the Cyberinfrastructure Enhancement (CE) Core is to strengthen the partner network, scale clinical
accomplishments made in overcoming health disparities during COVID-19 and create a sustainable growth
model for clinical and translational infrastructure and workforce development in our state. To accomplish this
vision, we will provide, update, and maintain “state of the art” computing and informatics resources; further
developing the infrastructure to support the clinical and translational research projects of LA CaTS investigators
with the goal of reducing Louisiana's chronic disease burden. We will accomplish our goals by pursuing the
following specific aims. Aim 1. To facilitate clinical and translational research administration and data
management using secure and proven cyberinfrastructure resources and tools, providing investigators a
common ground through which to conduct research. We will accommodate hybrid working scenarios brought
about by the COVID pandemic, by adapting such a toolset to be as effective remotely, as it is from the
researcher's clinic or office. Aim 2. Provide resilient video conferencing resources to support telehealth,
educational, and community engagement efforts across the state which will enhance communication during the
COVID-19 pandemic and beyond. CE will leverage the high-speed networks of Louisiana Optical Network
Infrastructure (LONI) and a palette of proven technologies to support investigators and communities with known
health disparities and poor access to information and care. Aim 3. To leverage existing web-based tools for
disseminating general information and for enhancing communication among all LA CaTS cores. CE will provide
and support an advanced central coordination point for both internal and external communication that will serve
as the primary repository of information about the LA CaTS Center for technical and lay audiences alike. The
completion of these aims will significantly enhance and support investigators in their goal to improve health
outcomes and address disparities in Louisiana by providing a wealth of computing resources that will greatly
facilitate their research. Tighter collaboration with all cores will yield a more tailored approach highlighted by
adoption, extension, and customization of available applications as well as the required infrastructure to provide
scalable and reliable cyber solutions for all LA CaTS investigators.